Development of Capillary-on-Chip for the Study of Preservation Injury on Microvascular Endothelial Cells

Abstract:
With nearly 90% of the demand for organ transplantation not being met worldwide, there is a current crisis in the
field of organ transplantation. A critical bottleneck preventing the expansion of transplant is that current limits in
preservation times are in the timescale of hours rather than days. This lack of storage time is perhaps most
critical in vascular composite allograft (VCA) transplantation, as longer times are needed for immunologically
and aesthetically matching the donor and recipient. This is even more so recently as novel mixed-chimerism
based tolerance induction protocols require the donor organ to be kept viable for several days. Literature has
shown that ischemic reperfusion injury (I/R) is a significant component of this preservation related damage.
Though it has been well documented that endothelial cells are extremely susceptible to I/R, there has been little
work done to study this in the context of organ preservation. Furthermore, our group has observed significant
endothelial damage, particularly in the microvasculature following static cold storage preservation, the current
clinical standard. As such, it is imperative that we better understand the effect of preservation injury on the
microvasculature and develop novel therapeutic strategies to treat these cells as a means to increase patient
access to organ transplant. In this study, we aim to establish a microfluidic model of the microvasculature to
determine the effects of preservation injury on primary microvasculature endothelial cells (MVECs) and how this
differs from their macrovascular counterparts. We further plan to alleviate this damage via apoptosis inhibition.
Our first aim will be to develop a microfluidic device to dynamically observe the detrimental effects of preservation
injury on rat primary MVECs and how this differs from macrovascular endothelial cells. Once the device has
been developed and optimized we will test novel methods to alleviate the preservation injury observed through
apoptosis inhibition. Our final goal will be to ascertain whether the preservation damage, and subsequent
treatments are conserved at the total organ level, with VCA being our model of choice due to their increased
susceptibility to endothelial damage. This will be accomplished through the use of an ex vivo machine perfusion
rat hindlimb model of VCA preservation and recovery. The completion of the proposed project will provide critical
in vitro, and ex vivo results for the effect of preservation injury on the microvasculature and how to remedy it.
Additionally, the study will lead to the development of a physiologically relevant benchtop model of vasculature
preservation that can be easily adapted for other organs such as the heart, lungs, and kidneys. Furthermore, the
results from this study will provide critical preliminary data for the basis of a planned K99/R00 Grant application
that will enable the applicant to develop a co-culture microfluidic model and to perform a preclinical in vivo study.
Finally, the work in this study will serve as an excellent opportunity for the applicant to receive surgical training
that will be critical for his career development.

Public health relevance
Project Narrative There is a critical need to improve organ preservation times for organ transplant, but unfortunately, many of the current protocols lead to damage of the endothelium. In the proposed project a novel microfluidic vasculature model consisting of primary microvascular endothelial cells will be developed and compared to a rat hindlimb machine perfusion model to understand the role of preservation injury in the microvasculature and how it can be prevented. This will lead to an increase in endothelial focused preservation therapies and subsequently increase the preservation potential of vascular composite allografts, along with other organs such as heart, lung, and kidney, expanding the potential donor pool and patient access to organ transplantation.